Look AHEAD Sleep: Sleep-disordered breathing, circadian rest/activity rhythms, and the risk of Alzheimer's disease and related dementias in Look AHEAD

Project Summary
Sleep disordered breathing (SDB) and altered circadian rest/activity rhythms (CRARs) are increasingly
recognized as risk factors for Alzheimer’s disease and related dementias. Obesity and type 2 diabetes (T2D)
are leading lifestyle risk factors for poor cognitive outcomes, and are closely linked to SDB and circadian
alterations. The roles of SDB and altered CRARs in the promotion of cognitive decline and dementia risk,
however, have not been well studied in older overweight or obese individuals with T2D, who are already
vulnerable to cognitive decline. The proposed ancillary investigation to the Look AHEAD Study will quantify
SDB and CRARs (through home sleep testing and wrist actigraphy) and will use a validated telephone
cognitive assessment protocol in 1,500 Look AHEAD participants, to evaluate the links of SDB and altered
CRARs with cognitive decline and adjudicated clinical conditions: mild cognitive impairment, Alzheimer’s
disease, and Alzheimer’s disease related disorders, in this cohort. We will investigate ~20-year diabetes
control and weight trajectories, and APOE ε4 carrier status as potential effect modifiers, and explore blood
based biomarkers of Alzheimer’s disease (Aβ42/Aβ40, total tau, pTau181, and NfL). Finally, we will leverage
Look AHEAD’s randomized controlled trial design to examine whether participants who were randomized to an
intensive lifestyle intervention (ILI) that targeted diet and physical activity (vs. a diabetes support and education
(DSE) control condition) exhibit lower rates of SDB and more robust, less phase-delayed CRARs in later life.
We will determine whether differences in these SDB/circadian characteristics are associated with maintenance
of cognitive function in older adulthood. Results of this study—conducted by a team of investigators with
expertise in aging, sleep, diabetes, and cognitive decline and Alzheimer’s disease—will advance our
understanding of how SDB and altered CRARs affect brain health among older adults with T2D and
overweight/obesity, and whether a lifestyle intervention produces durable effects on sleep/circadian health that
translate into sustained brain health in this at-risk population.

Public health relevance
Project Narrative Obesity and type 2 diabetes (T2D) are leading lifestyle risk factors for Alzheimer’s disease and are closely tied to sleep disorders. Sleep disordered breathing (SDB) and altered circadian-rest-activity-rhythms (CRARs) are, in turn, risk factors for dementia. The contributions of SDB and CRAR to dementia risk have not been well studied in older overweight/obese individuals with T2D. The proposed Look AHEAD Sleep study will use an in- home sleep assessment protocol to evaluate the association between SDB/CRAR and cognitive decline, mild cognitive impairment, Alzheimer’s disease, Alzheimer’s disease related disorders, and Alzheimer’s pathology (measured by blood based biomarkers). We will further examine potential effect modification by diabetes control and weight trajectories, sex, and APOE ε4 carrier status. Finally, within the setting of the Look AHEAD trial, we can test the long-term effects of an intensive lifestyle intervention on SDB and CRARs.